Community-based fetal ultrasound and care navigation: An approach to engaging pregnant women with substance use disorder in prenatal care and substance use treatment

Project Summary
Background: Pregnant women with substance use disorders (SUDs) experience significant barriers to prenatal
care and SUD treatment, magnified for NIH-designated populations with health disparities (HDPs; e.g.,
minoritized, low-income, rural). Often underserved and under-studied, women with SUDs and their children have
inequitable health outcomes compared to non-substance using women and compared to those from non-HDPs.
Although effective, evidence-based treatments for SUDs exist, they currently reach only 10-40% of pregnant women
with SUDs across the nation, with multi-level structural and systemic barriers for marginalized populations. To
adequately address the complex issues leading to health disparities among pregnant women and children
impacted by SUDs, we must be successful at engaging women by removing barriers, empowering care choices,
and ensuring equitable treatment availability and delivery. This preliminary study brings together
interprofessional expertise, novel tools, and innovative care delivery approaches to explore a potentially low-cost
translatable approach with potential to transform the state of health equity among individuals at high risk for
maternal morbidity and mortality (MMM). Fetal ultrasound imaging has emerged as a potential tool in the
promotion of mental-fetal connection, linked to enhanced engagement in prenatal care and SUD treatment.
Study Design: To address MMM in HDP pregnant women with SUDs we will test a multi- component intervention
involving individual components previously tested by our team: a novel ultrasound-based protocol implemented
in the community, developed through 20 years of fetal neurobehavioral research (NEXUS: Neurobehavior,
Engagement, ConneXion through UltraSound), integrated with patient navigation and care coordination. This
sequential explanatory mixed-methods study will test the feasibility and acceptability (Aim 1) and preliminary
effects (Aim 2) of the multi-pronged NEXUS intervention, versus a comparator, in n=60 pregnant individuals with
SUDs. We will explore factors related to implementation (Aim 3) to contribute key data for future larger-scale
trials and translational work to evaluate this approach as a potentially low-cost, accessible, sustainable method
for engaging women with prenatal care and SUD treatment. Even if the intervention is not successful, our
research aims will provide ample data to determine best practices and alternative strategies. Impact: Health care
is necessarily moving back into the community so the high risk of this project is a calculated one, with methods
that can be scaled and modified for sustainability. This study is built upon proven community engagement
strategies from this team’s previous work and attempts to address contributing factors related to social
determinants of health affecting this highly marginalized population of pregnant women experiencing SUDs. We
have developed partnerships with key community and state stakeholders to jointly evaluate the strategies,
outcomes, and plans for sustainability. All of the techniques planned for this program are easily translatable to
populations of pregnant persons with other risk factors including mental health conditions.

Public health relevance
Project Narrative This exploratory study brings together an interprofessional team, novel tools, and innovative, community driven care delivery approaches to transform the state of health equity among mother-infant dyads impacted by substance use disorder and subsequent high risk for poor health outcomes. This study will test community informed and community-based intervention using a novel ultrasound protocol, motivational and strength based education, and care coordination strategies to impact multiple levels of influence for the health disparities faced by these women and their children.